HUMAN ANTI CMV MONOCLONAL ANTIBODY IN INFANTS

This protocol is designed to evaluate the safety, tolerance and potential efficacy of at least three (and possibly four) dosages (1.0, 5.0 and 25.0 mg/kg plus possibly an intermediate dose between either 1.0 and 5.0 mg/kg or 5.0 and 25.0 mg/kg) of a human anticytomegalovirus monoclonal antibody, SDZ MSL-109, in the treatment of neonates with congenital cytomegalovirus infection.